Identifying the molecular signatures of mGlu receptor heterodimers

PROJECT SUMMARY
Glutamate, the major excitatory neurotransmitter in the brain, acts at both ionotropic and G protein-coupled
metabotropic glutamate (mGlu) receptors. The mGlu receptors are disulfide-linked dimers; when these
receptors are co-expressed in heterologous cells, group II and III protomers can heterodimerize, inducing
unique effects on receptor pharmacology in vitro and in native tissues. The observations that ligands can
differentiate between homomers and heteromers and exhibit distinct effects in the brain suggest that an
understanding of mGlu heterodimer expression and pharmacology will provide opportunities for precision
medicine approaches, in which select circuits might be specifically targeted for therapeutic purposes.
We have a particular interest in the mGlu7 receptor, which is emerging as a critical target in
neurodevelopment. For example, have shown that levels of mGlu7 are greatly (>65%) reduced in brain
samples from patients with the neurodevelopmental disorder, Rett syndrome. Several recent reports have also
described primary mutations within the GRM7 gene that cause seizures, developmental delay, ADHD, autism,
hypomyelination, and intellectual impairments. These data suggest that decreased mGlu7 levels are
detrimental and suggest that increasing receptor activity could be a novel therapeutic approach. As glutamate
exhibits an extremely low affinity and efficacy in activating mGlu7 compared to the other mGlu receptors, mGlu7
may primarily function constitutively; additionally, it has been proposed that mGlu7 may serve primarily as a
chaperone by partnering with other mGlu receptors in heterodimer form and that this may be the preferred
conformation of the receptor. If mGlu7 exists primarily as a heterodimer in vivo, drug development campaigns
for this receptor must consider the impact of mGlu7 heterodimerization on ligand pharmacology.
Here, we propose to use high throughput-compatible assays to measure activity of mGlu7-containing
heterodimers, with the goal of this R21 to provide the seed data needed for a larger, systematic platform to
identify tools for each mGlu receptor heterodimer. To support these studies, we will capitalize on a heterodimer
profiling technique that involves modifying the C-termini of the mGlu receptors with the “quality control system”
of the GABAB1 and GABAB2 receptors, which restricts surface expression to specific receptor combinations and
is amenable to HTS. The assay development in the current application will eventually allow us to capitalize on
our extensive collection of compounds (>20,000) that have already been generated and evaluated at mGlu
receptor homodimers at the Warren Center for Neuroscience Drug Discovery.

Public health relevance
PROJECT NARRATIVE The mGlu receptors are disulfide-linked dimers and when co-expressed in heterologous cells, specific family members can heterodimerize, inducing unique effects on receptor pharmacology in vitro and in native tissues. The mGlu7 receptor has emerged as a critical target in neurodevelopment, but drug discovery efforts for the target have focused on homomeric forms of the receptor. We propose to use high throughput-compatible assays to measure activity of mGlu7-containing heterodimers by employing a profiling technique that restricts surface expression to specific mGlu receptor combinations; this will allow us to capitalize on our extensive collection of mGlu receptor-targeted small molecules (>20,000) at the Warren Center for Neuroscience Drug Discovery.